REHABILITATION OF THE PARALYZED LARYNX

DESCRIPTION (Adapted from the Investigator's Abstract) Current treatments for bilateral laryngeal paralysis employ destructive surgical procedures that improve ventilation at the expense of voice production and airway protection. Functional electrical stimulation (FES) of the posterior cricoarytenoid (PCA) muscle restores vocal fold abduction, and offers a more dynamic and physiologic alternative to present treatment. The primary objective of the proposed research are: 1) to restore abduction in animals with bilateral vocal fold paralysis using a transcutaneous or indwelling stimulation device, 2) to determine the effects of chronic electrical stimulation on the eventual reinnervation of the PCA. Preliminary studies in the canine have suggested that FES not only restores laryngeal mobility, but prevents denervation atrophy while maintaining the viability and contractility of PCA muscle fibers. Surprisingly, FES has been observed to influence reinnervation of the PCA by selectively encouraging neural reconnection of intrinsic nerve fibers, while repressing reinnervation from foreign sources. Studies from the proposed research will span a four year period during which the effects of chronic FES on nerve and muscle will be fully documented. Such information is critical before studies of laryngeal pacing can be pursued in the implanted patient. Of particular interest is whether FES can reverse denervation atrophy if intervention is delayed. The timing of FES intervention and its capacity to rescue PCA fibers from atrophy and fibrosis will be assessed in terms of changes in muscle physiology and biochemistry. The effects of chronic FES on the extent and quality of PCA reinnervation following Recurrent Laryngeal Nerve (RLN) section and/or repair will be determined using physiological observations of laryngeal behaviors, HRP tracing studies, and muscle histochemistry. If FES is found to prevent or reverse denervation atrophy while promoting appropriate neural reconnection, a clinical model for bilateral paralysis in the canine will be used to study FES as a therapeutic approach. Commercially available devices will be evaluated for adaptation to laryngeal pacing. Further research toward the development of an injectable microstimulator will be pursued in an animal model. This new technology may offer significant advantage over emergency tracheotomy in cases acute bilateral paralysis.